B Lymphocytes in Autoimmune Disease

Rheumatoid arthritis (RA) results from a complex cascade of events that breaks immune
tolerance and culminates in the destruction of synovial tissue. Both genetic and environmental
factors contribute to disease. B lymphocytes (B cells) play a critical role, producing the
autoantibodies that trigger arthritis. The Kendall lab works toward understanding B cells that
support arthritis development. We originally used mice deficient in the B cell signaling protein
Bruton’s tyrosine kinase (BTK) to test its role in the K/BxN model of spontaneous autoimmune
arthritis. The studies indicated significant disease protection, accompanied by loss of
autoantibodies, with relative sparing of total IgG. In the course of this work, we made the new
discovery that BTK also affects the gut microbiome, commensal organisms that are thought to
play an important role in the development of autoimmune diseases, including RA. We found that
specialized immune organs in the gut, called Peyer’s patches, are very small, and that they
make low levels of IgA antibody that does not bind gut bacteria as well as it should. Further,
there is dysregulation of the microbiome that may have a protective effect against autoimmune
arthritis. The hypothesis underlying this proposal is that BTK-mediated signaling
supports mucosal immunity and regulates microbes that influence autoimmunity, to be
tested in Aims which: 1) define the IgA repertoire in Btk-deficient versus –sufficient K/BxN mice,
including features such as selection, clonality and evidence of somatic hypermutation, 2)
determine the cell-specific role of BTK in regulating the microbiome, differentiating between B
cell and myeloid cell functions, and 3) determine whether BTK expression and function in
myeloid and B cells differ in RA patients and controls, and whether IgA binding of commensal
bacteria are altered. This project has direct clinical importance in understanding how aberrant B
cells in autoimmune patients may cause microbiome shifts that modulate disease.

Public health relevance
The immune system defends against infections and cancer. B lymphocytes are part of the immune system. They produce antibodies to help in this fight. In addition, some antibodies help regulate normal healthy human bacteria called the microbiome. In autoimmune disease, these processes go awry. Antibodies attack the body and cause autoimmune diseases, like Rheumatoid arthritis (RA). The microbiome can also become dysregulated and may trigger autoimmune attacks. This proposal focuses on ways in which abnormal B cells and myeloid cells may also fail to regulate the microbiome, leading to worse disease outcomes. RA is one of the most common autoimmune diseases and has a disproportionate impact on women, a group of Veterans that has grown rapidly in recent decades. This proposal focuses on the effects B lymphocytes and the microbiome have on autoimmune diseases that affect our Veterans.